TREATMENT OF ORTHOSTATIC TACHYCARDIA

The overall goal of this project is to test the hypothesis that partial dysautomonia is the underlying pathophysiology for a signifciant portion of patients with orthostatic tachycardia. A secondary goal is to find effective treatment for this syndrome.